Biomarkers of Atopy Beginning Early (BABE)

PROJECT SUMMARY/ABSTRACT – OVERALL
Atopic dermatitis (AD) often precedes sensitization to food allergens and the development of clinical food allergy
(FA) due to compromised skin barrier function allowing allergen sensitization through skin. A large body of data
from Europe and North America suggest that living on farms is associated with a decreased risk of asthma and
atopic diseases. Asthma has been a focus of farming lifestyle studies; however, little is known about the
protective mechanisms of farming lifestyle on development of AD and FA which often precede respiratory
allergies and asthma. The farm lifestyle protection against allergic diseases comprises likely three prerequisites:
1) innate immune training and a modified immune response upon re-exposure, 2) generation of suppressive
regulatory T cells, and 3) preserved barrier function. Here, we propose to assess these preconditions in an
extended longitudinal birth cohort study among the Old Order Mennonites (OOM), a population practicing
traditional, single-family farming with a lower rate of asthma and allergic diseases, including atopic dermatitis
and food allergies in early childhood. Biomarkers of Atopy Beginning Early (BABE) will test the overall
hypothesis that perturbed skin barrier function, immune millieu and microbiome drive the development of atopic
dermatitis, Th2 inflammation, allergic sensitization and FA, whereas a healthy gut microbiome modulates the
protective metabolite pool such as short chain fatty acids and tryptophan metabolites and protective Treg
immune development. Project 1 utilizes deep metagenomic sequencing to assess infant gut microbiome
composition and corresponding metabolome to show that OOM infant gut microbiome is distinct from urban
infants. Project 2 assesses markers of allergic sensitization and protective immune development utilizing
multiparameter spectral flow, unbiased clustering analysis and transcriptomic studies to demonstrate that urban
infants have a higher number of hyperinflammatory monocytes and Th2-skewed T cell subsets detected in early
infancy, whereas OOM have gut-homing memory Tregs. Project 3 will characterize skin barrier function,
microbiome and immune cell transcriptome. Our longitudinal birth cohort ZOOM1, funded by a U01 grant, is
now 2-5 years old and is a shared foundation for the three projects (78 OOM and 79 urban). We will add another
120 infants as a ZOOM2 cohort (80 urban and 40 OOM). We will also replicate key T cell biomarkers in larger
infant cohorts (Start Eating Early Diet ”SEED” and Microbiome and Allergic Asthma Precision Prevention
“MAAP2”). The infrastructure to recruit, collect and share samples and data is provided by the Cohort Admin &
Biorepository and Data Management & Bioinformatics Cores. The Admin Core will provide overall financial and
administrative infrastructure. These studies aim to identify biomarkers, mechanisms, and protective strategies
against atopic and food allergy.

Public health relevance
PROJECT NARRATIVE – OVERALL COMPONENT The mechanisms and the biomarkers of developing food allergy are poorly understood, but it is known that traditional, agrarian lifestyle provides protection against atopic diseases starting in early life. In this proposal utilizing samples and clinical data from a longitudinal birth cohort study, we will evaluate the development of the microbiome, skin barrier function and skin and systemic immune system in urban infants at high risk for atopic diseases and in farming lifestyle infants. These studies will provide critical new knowledge about the biomarkers and mechanisms of early development of and protection against atopic diseases, and lay the groundwork for future studies of prevention of allergic diseases in childhood.